Detection of PD-1 inhibitory signaling and its molecular relays in T cells: Implications for cancer immunotherapy

PD-1 blocking agents have achieved significant success as anti-cancer therapeutics. The mechanism(s) of how
PD-1 compromises anti-tumor function remain poorly understood. Although in trans engagement of PD-1
expressed in T cells by its ligands expressed on APC or cancer cells inhibits T cell activation, evolving discoveries
provide evidence that PD-L1:B7-1(CD80) in cis and PD-1:PD-L1 in cis non-canonical interactions occur when
these molecules are co-expressed on APC, and disrupt the canonical interaction between PD-1 and PD-L1 in
trans and T cell inhibitory signaling. Thus, expression of PD-L1 in the tumor microenvironment (TME) is not
synonymous with PD-1-mediated T cell inhibition. We generated an antibody that recognizes PD-1pY248 (pPD-1),
which is required for PD-1 inhibitory signaling, and detected pPD-1 in mouse and human. We found pPD-1+ T
cells in cultures, in mouse tumor models and patient biopsies, but also in CD8+ T central memory (TCM) cells in
the peripheral blood of healthy individuals. In tumor bearing mice, pPD-1 was expressed in tumor infiltrating CD8+
T lymphocytes but mostly in Treg. We generated mice with conditional targeting of Pdcd1 gene (PD-1f/f) and
selectively eliminated PD-1 in Treg (Pdcd1f/fFoxP3cre). In tumor-bearing Pdcd1f/fFoxP3cre mice, Treg displayed
enrichment in pathways regulating lipid metabolism, fatty acid oxidation, and production of
monocyte/macrophage chemotactic protein-1 (MCP-1) and GABAergic neurotransmitter with known
immunosuppressive function. These features correlated with a significant increase of B cells and M2-like
macrophages, diminished activation of tumor infiltrating T cells, and increased tumor growth. Our results reveal
a previously unappreciated network by which Treg-selective blockade of PD-1 signaling reshapes the
immunological landscape and suggest that abrogation of PD-1 signaling in distinct cell types differentially impacts
the TME. Our findings indicate that pPD-1 is a powerful marker to identify T cells subjected to PD-1 inhibitory
signaling and support the novel hypothesis that cell-specific detection of PD-1 signaling by pPD-1 might predict
the outcome of checkpoint immunotherapy. To investigate these, we will pursue the following specific aims:
1. To identify the immunological and biochemical properties of pPD-1+ T cells in the context of cancer.
We will characterize pPD-1+ CD8+ TIL and Treg by single cell immunoprofiling, and investigate how T cell subset-
specific PD-1 signaling reshapes the TME by using our Pdcd1f/fCD8cre and Pdcd1f/fFoxP3cre mice.
2. To identify the molecular and functional properties of pPD-1+ cells in healthy individuals. We will
examine how PD-1 signaling shapes the properties of T cells in healthy individuals and in cancer patients and
uncover why only cancer-mediated PD-1 signaling induces TEX.
3. To determine expression, function and prognostic significance of pPD-1+ TIL in cancer patients. We
will examine cell-specific PD-1 expression and signaling in patient biopsies, co-expression of PD-1/pPD-1, PD-
L1 and CD80, and determine their prognostic significance.

Public health relevance
Project Narrative Activation of the immune system by immunotherapy can be used for the treatment of cancer but major gaps in our knowledge compromise optimal outcomes. This project will study how immunotherapy affects the properties of CD8+ T effector and T regulatory cells and their crosstalk with other immune components of the tumor microenvironment. This work may significantly improve the outcome of immunotherapy and provide a major benefit to cancer patients.